Admin-Core-001

The overall goal of the Administrative Core is to provide leadership and general administration related to all
aspects of the program project ‘Integrative Analysis of Lung Cancer Etiology and Risk’. This Core will be
responsible for integrating the scientific disciplines and study sites into a unified interdisciplinary approach.
This approach is focused on working with large-scale collaborative efforts that are systematically evaluating
smoking behaviors and lung cancer etiology, large-scale studies of genetic variation and impact on lung cancer
risk, and development and evaluation of biomarkers that inform risk for lung cancer development. To achieve
our goals, our scientific agenda comprises a series of three inter-related program projects. Our team of
investigators is multidisciplinary, building upon our complementary strengths. This Core will be responsible for
managing all project and core resources and will ensure compliance with all governmental and specific NIH
regulations and requirements, including timely communication and consultation with project offices and other
NCI staff. The core will convene all necessary meetings, including monthly meetings of the internal steering
committee and annual meeting of the external scientific advisory committee. In addition, monthly webinars will
be organized to bring together speakers with expertise in the various disciplines upon which this proposal is
composed.
The specific aims of this Core are: Specific Aim 1. Maintain and further develop a database for
epidemiological and genetic data. This aim supports a large database of harmonized epidemiological data and
also provides support for distribution of matching genetic information.
Aim 2. Perform Integrative Support for Program Project Activities. The primary function of this core is to
ensure the efficient functioning of Program Project relationships and communication. Aim 3. Ensure
compliance of the Program Project with all Regulatory Requirements. The administrative core supports
the development of protocols that support studies. It also coordinates relationships with dbGAP and other
entities for whom data transfers are required or requested. It will also manage all communications with NCI
programmatic, technical and administrative staff. Aim 4. Provide fiscal oversight and management. The
administrative core oversees financial management and ensures timely management of financial relationships
among the Projects and Cores.

Public health relevance
The overall goal of the Administrative Core is to provide leadership and general administration related to all aspects of the program project ‘Integrative Analysis of Lung Cancer Etiology and Risk’. This Core will be responsible for integrating the scientific disciplines and study sites into a unified interdisciplinary approach. The Core manages databases and communication within the Program Project and with NIH and collaborating groups and facilitates data transfer and resource sharing.